Multidimensional and longitudinal immune profiling of sepsis in Uganda

PROJECT SUMMARY
The global burden of sepsis is overwhelmingly concentrated in sub-Saharan Africa (SSA), where nearly 40% of
all sepsis cases occur and up to 65% of all deaths are sepsis-related. While sepsis outcomes have improved
over time in high-income countries (HICs), outcomes remain poor in SSA, with short-term mortality between 20-
50%. Further, sepsis treatment protocols developed in HICs have repeatedly shown harm when implemented in
SSA. We argue that an imprecise understanding of sepsis pathobiology in SSA is a fundamental barrier to the
development of effective treatment strategies. In contrast with HICs, sepsis in SSA occurs primarily in younger
adults, inciting pathogens are diverse, and HIV/AIDS is a major driver of poor outcomes. Despite this distinctive
landscape, locally relevant models of sepsis pathobiology are scarce. Our overarching hypothesis is that unique
demographic and pathogen profiles inherent to sepsis in SSA, including a high burden of comorbidities such as
HIV/AIDS, underlies heterogenous sepsis pathobiology and treatment responses. In this project, we will apply
and improve upon precision medicine strategies used in HICs to establish pathobiologically-driven and
therapeutically relevant sepsis subtypes (“endotypes”) in SSA. Using RNAseq and machine learning in a pilot
cohort, our Uganda-based team has demonstrated, for the first time, the presence of two sepsis endotypes in
SSA that are reflective of host-pathogen features unique to the region and differentiated by targetable
pathobiological mechanisms and risks of multiorgan dysfunction and death. In a multicenter prospective cohort
study in Uganda, we will validate these findings and infer relevant biological pathways to pinpoint mechanisms
driving sepsis outcomes in Aim 1. Leveraging this cohort in Aim 2, we will apply high-dimensional proteomics to
define longitudinal immune response trajectories underlying sepsis outcomes beyond hospital mortality,
including functional disability in sepsis survivors. Our preliminary data from Uganda also suggests there are
unique aspects of sepsis pathobiology in persons living with HIV (PLWH), including exaggerated production of
pro-inflammatory cytokines and alarmins, expansion of T-reg and aberrant NK cells, and upregulation of immune
checkpoint T-cell exhaustion pathways. In Aim 3, we will perform in-depth immunophenotyping to develop a
working mechanistic understanding of sepsis in PLWH. In all three Aims, we will leverage established sepsis
research infrastructure in Uganda and multidisciplinary collaborations between critical care and infectious
disease physician-scientists, immunologists, and bioinformaticians/biostatisticians at Columbia University and
Uganda Virus Research Institute. Results from this project will (i) illuminate crucial domains of sepsis
pathobiology in the global hotspot of SSA and (ii) translate these insights to classify individual sepsis patients
into pathobiologically-driven and therapeutically relevant subgroups. Ultimately, our data will inform design of
the first clinical trial of precision, host-directed treatment for sepsis in SSA, results of which will enhance delivery
of effective sepsis therapeutics worldwide.

Public health relevance
PROJECT NARRATIVE The global burden of sepsis is concentrated in sub-Saharan Africa, where poor understanding of sepsis pathobiology is a fundamental barrier to the development of effective treatment strategies. The goal of this project is to stratify sepsis patients in Uganda into biologically driven and therapeutically relevant subtypes. Our results will inform design of the first precision medicine clinical trial of sepsis treatment in sub-Saharan Africa and improve sepsis treatment outcomes in high HIV-burden settings worldwide.